COMPUTER ANALYSIS OF ULTRASOUND IMAGES OF THE TONGUE

An image-processing system has been developed for a Macintosh II personal computer. It is designed to process individual sagittal tongue sections that are digitized in real time and stored in standard TIFF format. The successive processing steps are: (1) a prefilter for noise reduction, (2) a geometrical transformation (polar coordinates), (3) an enhancement of the tissue/air interface in the surface region of the tongue by matched filtering, and (4) an extraction of border points by searching for an optimal radial path along the angular dimension. This latter task is performed very efficiently using dynamic programming, which has several advantages. First, the procedure is very robust, due to the use of a global criterion to guide the detection. Second, the extracted contours are smooth as a result of appropriate restriction of the allowable transitions. Finally, the method allows an optional specification of some predefined contour points. This system was implemented into a program that can handle image sequences in a fully automatic mode.